Advancing Neurosurgical Neuronavigation Using Resting State MRI and Machine Learning

PROJECT SUMMARY
Our team has developed a machine learning (ML) algorithm that provides highly accurate prognostic
information neurosurgeons can use to advise brain tumor removal. While this algorithm holds great promise
with regard to surgical decision-making and patient outcomes, it also raises significant ethical issues and risk
factors. Proactively identifying relevant ethical issues and exploring possible solutions can improve the
effectiveness, benefits, and uptake of this technology, while also mitigating potential harm to patients and
suboptimal surgical decision-making.
We propose a 12-month bioethics research supplement that will collect original data on stakeholder
perspectives about research and clinical practice involving this novel ML algorithm. Data can inform ethical and
responsible implementation of this technology and will begin to lay the groundwork for developing ethical
solutions and guidance to maximize patient wellbeing and support surgeon decision-making as they balance
patient and caregiver needs, their professional judgment, and ML-generated surgical insights. The research
team has experience in brain mapping, neuroethics, stakeholder engagement, and the responsible conduct of
research and clinical practice. We propose the following aims:
Aim 1. Explore the perspectives of patients (N = 15) with malignant brain tumors about perceived benefits,
drawbacks, concerns, and risk factors in utilizing a ML algorithm for predicting prognosis and surgical decisions
for severe brain tumors.
Aim 2. Explore the perspectives of caregivers of patients (N = 15) with malignant brain tumors about perceived
benefits, drawbacks, concerns, and risk factors in utilizing an ML algorithm for predicting prognosis and
surgical decisions for severe brain tumors.
Aim 3. Explore the perspectives of neurosurgeons (N = 15) who treat patients with malignant brain tumors
about perceived benefits, drawbacks, concerns, and risk factors in utilizing an ML algorithm for predicting
prognosis and surgical decisions for severe brain tumors.

Public health relevance
Project Narrative Our team has developed an advanced, first-of-its-kind machine learning (ML) algorithm intended to provide prognostic information about severe brain tumors and advise decisions about neurosurgery. The capacity to obtain and make treatment decisions based on artificial intelligence-generated insights raises myriad ethical considerations and risk factors. This project will systematically collect original data via in-depth interviews with three relevant stakeholder groups (i.e., patients with brain tumors, caregivers of patients with brain tumors, neurosurgeons) to identify shared and unique needs, values, concerns, priorities, and perceived risks and benefits of using this technology both in research and clinical settings.